Development of novel therapeutics for cancer cachexia

PROJECT SUMMARY / ABSTRACT
Cancer-induced skeletal muscle atrophy is a central and defining feature of the cancer cachexia syndrome, a
highly prevalent condition that affects over 50% of patients with advanced cancer and over 500,000 patients
per year in the U.S. In addition to being highly prevalent, cancer-induced skeletal muscle atrophy has
devastating consequences for patients; it reduces physical function and quality of life, often complicates or
precludes cancer treatment, and strongly predicts early mortality from cancer. Unfortunately, a pharmacologic
therapy for cancer-induced muscle atrophy does not exist. Thus, cancer-induced skeletal muscle atrophy
represents a highly significant unmet medical need with broad relevance to cancer patients. A major goal of
Emmyon, Inc. is to discover and develop a pharmacologic therapy for cancer-induced skeletal muscle
atrophy. To that end, we recently discovered a natural compound that significantly reduces cancer-induced
muscle atrophy in five well-established and distinct in vivo mouse models of cancer. We then used that natural
compound as a lead in medicinal chemistry program and discovered and patented a confidential and
proprietary chemical derivative (EMMY1-06) that appears to be significantly more potent and more efficacious
than the lead compound in at least two distinct mouse models of cancer-induced muscle atrophy. In this
Phase II SBIR proposal, we seek to continue this exciting work by advancing the development of
EMMY1-06 and related molecules as pharmaceuticals for cancer-induced skeletal muscle atrophy.
Specifically, we will further investigate EMMY1-06's safety, efficacy, and mechanisms of action in several
distinct and complementary mouse models of cancer-induced muscle atrophy that involve multiple tumor types,
sexes, and ages; these studies will significantly advance EMMY1-06 towards clinical development and
commercialization in SBIR Phase III. In parallel to our detailed studies of EMMY1-06, we will also design,
synthesize, and characterize novel compounds that are structurally related to EMMY1-06, seeking to discover
additional compounds with pharmacologic properties that are similar to or perhaps even better than those of
EMMY1-06 in preclinical models of cancer-induced muscle atrophy. Together, these studies will rigorously
advance the scientific understanding and commercial development of a highly promising new class of
pharmaceutical agents. Through this work, we hope to ultimately discover and develop a new
pharmacologic therapy that could broadly improve clinical outcomes for millions of patients who
suffer from cancer.

Public health relevance
PROJECT NARRATIVE In patients who suffer from cancer, muscle wasting is very common and has devastating consequences, including reduced quality of life and overall health, interference with cancer treatment, increased complications from cancer treatment, and reduced survival. Unfortunately, right now, we do not have any medicines to help prevent or treat muscle wasting in patients suffering from cancer. To help address this issue, we propose a Phase II SBIR study to investigate and develop new and promising potential medicines for cancer-induced muscle wasting.